Effects of general vs. regional anesthesia on infant neurodevelopment and apnea

DESCRIPTION (provided by applicant): Each year large numbers of children undergo surgery involving exposure to general anesthesia. Whether such exposure increases a child's neurodevelopmental risk has never been established. Studies in animal models provide compelling evidence that commonly used agents (e.g., isoflurane, midazolam, nitrous oxide) enhance neuronal cell death in the immature brain, in some studies at doses lower than those required to achieve a surgical plane of anesthesia. The clinical implications of these data are controversial, however, because no prospective study has evaluated neurodevelopment in children after exposure to anesthetic agents in infancy. This application seeks funding for U.S. participation in an international, prospective, multi-site, randomized, controlled, equivalence trial comparing children's neurodevelopment following receipt of general or regional awake anesthesia. A total of 220 infants who undergo inguinal herniorrhaphy, a common surgery that can be performed using either form of anesthesia, will be enrolled at 9 sites in the USA over a 27-month period. Because a total of 24 patients have been enrolled during our pilot phase, an additional 196 patients will be enrolled during this project. An additional 440 infants will be enrolled at sites in Australia and the United Kingdom, for a total enrollment of 660. Funding has been obtained for the non-USA sites. The primary hypothesis is that neurodevelopmental outcomes at 2 years of age are equivalent in children who received general anesthesia or regional awake anesthesia. The primary endpoint will be the Cognitive score on the Bayley Scales of Infant and Toddler Development-3rd edition (BSID-III). Secondary endpoints include the Language and Motor Composite scores on the BSID-III, scores on the MacArthur-Bates Communicative Development Inventory, and neurologic status. The secondary hypothesis is that apnea rates in the first 12 post-operative hours are equivalent in the treatment groups. Multiple linear or logistic regression analysis, adjusting for potential confounders, will be used to estimate treatment group differences. The primary hypothesis of equivalence in Cognitive score at 2-years of age will be accepted if the 2-sided 95% confidence interval of the adjusted treatment group difference in means lies within -5 and +5 points. In light of the widespread use of general anesthesia in infant surgery, the results are likely to have substantial public health implications.

Public health relevance
PUBLIC HEALTH RELEVANCE: If general anesthesia is neurotoxic to infants under conditions of clinical use, the public health implications would be substantial given the frequency with which such agents are used in infant surgery. If general and regional awake anesthesia result in neurodevelopmental outcomes that are equivalent, this would support the safety of general anesthetics as currently used. PROJECT NARRATIVE If general anesthesia is neurotoxic to infants under conditions of clinical use, the public health implications would be substantial given the frequency with which such agents are used in infant surgery. If general and regional awake anesthesia result in neurodevelopmental outcomes that are equivalent, this would support the safety of general anesthetics as currently used. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The primary aim of this prospective, randomized, multi-site, clinical equivalence trial, the General Anesthesia Study (GAS), is to determine whether different types of anesthesia (general vs. regional awake) given to neonates and young infants undergoing inguinal hernia repair result in comparable neurodevelopmental outcomes. The secondary aim is to compare the frequency and characteristics of apnea in the post-operative period after general or regional awake anesthesia. The proposed randomized trial will be conducted in the United States of America (USA), the United Kingdom/Europe, Canada, and Australia/New Zealand. Funding for the UK/Europe arm of the trial has been obtained from the Health Technologies Assessment program, managed by the NIHR Coordinating Center for Health Technology Assessment. Funding for the Australian/New Zealand arm of the trial has been obtained from: the Australian National Health and Medical Research Council, the Murdoch Children's Research Institute, and the Australian and New Zealand College of Anaesthetists. This application requests funds to expand this trial from its current pilot phase at Children's Hospital Boston to encompass a total of 9 participating sites in the USA. A total of 24 U.S. patients have been enrolled to date. We intend to enroll, over a period of 27 months, an additional 196 infants who have not previously been exposed to general anesthesia. The total number of infants who will be enrolled in the trial, i.e., at the USA, UK/Europe, and Australia/New Zealand centers combined, is 660. Primary Hypothesis: Neurodevelopmental outcome at 2-years of age is equivalent in children who receive general anesthesia or regional awake anesthesia for inguinal hernia repair. The primary endpoint will be the score on the Cognitive scale of the Bayley Scales of Infant and Toddler Development-Third Edition (BSID-III). Other endpoints that will be considered in evaluating the primary hypothesis include the Language, Motor, and General Adaptive Composite scores from the BSID-III, scores on the MacArthur-Bates Communicative Development Inventory, and status on neurological examination (including vision and hearing screening). Secondary Hypothesis: Post-operative apnea rates are equivalent in infants and young children who receive general anesthesia or regional awake anesthesia for inguinal hernia repair. This endpoint will be assessed using apnea monitors. Apnea will be defined on the basis of vital signs, specifically as a pause in breathing of greater than 15 seconds or a shorter pause associated with oxygen saturation <80% or bradycardia (20% fall in heart rate). Responsiveness to the Funding Opportunity Announcement PAR-07-416, "Developmental Pharmacology" The multidisciplinary research proposed in this application is responsive to the research objectives of PAR-07- 416, as indicated by the following excepts from this Funding Opportunity Announcement (italics added): "This initiative seeks to stimulate interdisciplinary collaboration of clinical, translational and basic researchers working in complementary areas of research in developmental therapeutics." "The long-term goal of this initiative is to provide the scientific basis for the rational use of drugs in children of all ages. Proposals developed as a result of this initiative must be "patient oriented" and designed to answer research questions of clinical significance." "Systems models...assessing the sensitivity of the CNS... to therapeutic drugs (eg anesthetics)..." and "Characterization of acute and long-term changes in CNS development due to drug therapies on behavioral and cognitive outcomes"